Sustainable Community Clinic Telemedicine-Based Glaucoma Screening

Project Summary
There is a critical need to study innovative strategies to better engage populations of people most at risk of
glaucomatous vision loss and least likely to have access to an eye care provider. Community clinics such as
federally qualified health centers or free clinics provide care for people who live in poverty. Because these
people are disproportionately of minority race and ethnicity, community clinics provide care for people who are
at higher risk of: 1) having glaucoma and 2) not getting adequate specialty treatment for glaucoma. Glaucoma
remains a leading cause of blindness even though effective treatments exist. Our objective is to address the
critical logistical and psychosocial barriers – cost, transportation, trust in the provider and skepticism that that
an asymptomatic disease will lead to blindness – that limit access of vulnerable populations to glaucoma care.
The scientific premise is based on evidence of the effectiveness of telemedicine approaches to glaucoma
screening that have improved access to services for vulnerable populations. Our central hypothesis is that
providing comprehensive glaucoma screening and follow-up care through the community-based free clinic
infrastructure will establish a sustainable approach to decreasing logistical and psychosocial issues and
improve vision outcomes for this vulnerable population. We will use community-engaged research strategies to
understand key barriers to accessing eye care for uninsured and underinsured adults through semi-structured
interviews. We will build upon a trusting partnership among academic (University of Michigan, UM) and
community clinics (Hope Clinic, Ypsilanti, MI and Hamilton Clinic, Flint, MI) by forming a Community Advisory
Board to engage these communities in glaucoma screening efforts. We will use a telemedicine-based
glaucoma screening approach in the two clinics. Ophthalmic technicians will gather automated eye screening
data at the clinic sites and transmit the data to an ophthalmologist at the UM who interprets screening
information and conveys recommended follow-up care remotely. Ophthalmologist resources will be used more
efficiently, since they do not need to be co-localized with the patient to provide high quality screening care. The
burden on patients’ time is also reduced. Screening is conducted locally at trusted locations, and only patients
who screen positive for disease travel to specialty clinics. Low-cost glasses will be provided through publicly
available infrastructure. We will assess the prevalence of glaucoma and other blinding eye diseases and the
screening cost per case detected. We will use community input to refine an eHealth-based personalized
counseling and education program to improve adherence to glaucoma follow-up care recommendations. We
will evaluate the effect of this intervention on follow-up adherence compared to standard education in a
randomized controlled trial. Programmatic costs will be evaluated. This proposal is a first step toward our long-
term goal to eliminate disparities in glaucoma outcomes by leveraging community-engaged research to bring
specialty care to vulnerable populations.

Public health relevance
To decrease the prevalence of preventable blindness due to glaucoma, we need to: 1) screen high risk people from vulnerable populations, and 2) ensure people with glaucoma from these vulnerable populations receive and adhere to treatment. Community clinics are key resources to utilize for providing glaucoma screening and care coordination. Leveraging tele-health to provide comprehensive glaucoma screening, education and follow-up care through the community clinics will provide a sustainable approach to glaucoma care for the vulnerable populations these clinics serve.